Role of HIPK2 in Kidney Tubulointerstitial Injury

DESCRIPTION (provided by applicant): HIV-associated nephropathy (HIVAN) is a leading cause of end stage kidney disease among African-Americans. Despite growing knowledge of the disease mechanism, therapeutic options have been limited. While gene expression microarray has been widely applied for the study of kidney diseases, data analytical tools are quite limited. Here we propose a novel approach to link the microarray data to the upstream signaling kinase activation using computation/systems biology approach. To accomplish this, we have developed several computational programs including Gene2 Network, a system that uses protein-protein interactions and cell signaling networks to build subnetworks based on seed lists of genes, and kinase enrichment analysis (KEA), a tool that links lists of proteins to the kinases most likely regulating their activity. Using this approach to study the kidney disease in a HIV-1 transgenic mouse model (Tg26 mice), which is a well-characterized animal model for human HIVAN, we identified that homeodomain interacting protein kinase 2 (HIPK2) is a novel upstream kinase regulating the transcription factors and genes activated in kidneys of Tg26 mice. HIPK2 is known to be involved in the regulation of p53, TGF-2, Wnt/2-catenin, and Notch pathways, which are known to mediate apoptosis and fibrosis in kidney disease including HIVAN. Our preliminary data suggest that HIPK2 protein expression is increased markedly in the renal tubulo-interstitial compartment of Tg26 mice and human with HIVAN. In addition, HIPK2 mediates HIV-induced apoptosis and epithelial-mesenchymal transition (EMT) of renal tubular epithelia cells, contributing to kidney fibrosis. Based on these preliminary data we hypothesize that HIPK2 is an upstream protein kinase that mediates tubulointersitial injury in HIVAN and in other kidney diseases. To test our hypotheses, we propose the following specific aims: Specific aim 1: Examine the role of HIPK2 in vitro by confirming the role of HIPK2 in apoptosis and EMT of HIV-infected cells and by determining signaling pathways up- and down-stream of HIPK2 that are activated by HIV. Specific aim 2: Confirm the role of HIPK2 in vivo by investigating whether HIPK2 knockout mice are protected from the development of tubulointerstitial injury in the unilateral ureteral obstruction model and by assessing the effect of HIPK2 knockout on the development of tubulointerstitial injury in Tg26.

Public health relevance
PUBLIC HEALTH RELEVANCE: HIPK2 could be a novel upstream kinase activating multiple downstream pathways leading to tubulo-interstitial injury, which is a final common pathway in the progression of chronic kidney disease. HIPK2 could be a potential new therapeutic target for the treatment of HIV-associated nephropathy as well as other kidney diseases. Our studies will also provide a novel approach to link upstream signaling pathways to data from gene expression microarray, which could help us to identify key upstream kinases responsible for kidney injury in HIVAN, as well as in other diseases. NARRATIVE HIPK2 could be a novel upstream kinase activating multiple downstream pathways leading to tubulo-interstitial injury, which is a final common pathway in the progression of chronic kidney disease. HIPK2 could be a potential new therapeutic target for the treatment of HIV-associated nephropathy as well as other kidney diseases. Our studies will also provide a novel approach to link upstream signaling pathways to data from gene expression microarray, which could help us to identify key upstream kinases responsible for kidney injury in HIVAN, as well as in other diseases. __SpecificAimsTextDelimiter__ A. HYPOTHESIS AND SPECIFIC AIMS HIV-associated nephropathy (HIVAN) is a leading cause of end stage renal disease among African-Americans. Despite growing knowledge of the disease pathogenesis, therapeutic options have been limited. Gene expression microarrays have been widely applied for the study of kidney diseases, including HIVAN. Although gene expression profiling can be used to deduce pathways implicated in the pattern of expression, this approach is not directly reflective of signaling activation, which normally occurs through changes in the phosphorylation status. Here we propose a novel approach to characterize signaling pathway activation by taking into account protein-protein and protein-DNA interactions. As shown in Figure 1, we used this approach to study HIVAN in a well-established murine HIVAN model (Tg26). From experimental data generated from Protein/DNA interaction array (Affymatrix/Panomics(R)) and gene expression microarrays we compiled a list of consensus transcription factors (TFs) that are differentially activated in Tg26 relative to their wild-type littermates (WT). To link the TFs to signaling pathways we utilized databases of protein-protein interactions (PPIs) and signaling pathways to generate a subnetwork connecting the TFs to known PPIs. A list of protein kinases most likely to regulate the phosphorylation of the proteins within this subnetwork was then compiled using a web-based tool called Kinase Enrichment Analysis (KEA), which we had developed. With this approach we identified the homeo-domain interacting protein kinase 2 (HIPK2) as a common regulator of many components within this subnetwork. HIPK2 is known to be involved in the regulation of p53, TGF-β, Wnt/β-catenin, and Notch pathways, which are known to be involved in kidney disease. HIPK2 has never been studied in this context. We experimentally confirmed that HIPK2 is highly expressed in the renal tubulo-interstitial compartment of Tg26 and in humans with HIVAN. Interestingly, HIPK2 protein expression is increased in Tg26 without a change in mRNA level. Our in vitro experiments demonstrate that HIV-1 infection increases HIPK2 protein expression. We also found that HIPK2 mediates HIV-induced apoptosis and epithelial-mesenchymal transition (EMT) in cultured Renal Tubular Epithelial Cells (RTEC). The strength of our approach is substantiated by the fact that the identification of HIPK2 would not have been possible with traditional gene-expression-based pathway analysis, since the mRNA expression of HIPK2 is the same between Tg26 and WT. Based on these preliminary data we hypothesize that HIPK2 is an upstream protein kinase that mediates tubulointersitial injury in HIVAN and other kidney diseases. The integrated data analysis of gene expression microarrays, Protein/DNA arrays, and graph-theory- inspired computational systems biology is a novel approach to link mRNA expression profiles to upstream signaling pathways. To test our hypotheses, we propose the following specific aims: Specific aim 1: Examine the role of HIPK2 and the signaling pathways mediated by HIPK2 in HIVAN 1A: Confirm the role of HIPK2 in apoptosis and EMT of HIV-infected RTEC. 1B: Determine the signaling pathways up- and down-stream of HIPK2 Figure 1. A novel approach to characterize signaling pathway activation in HIVAN. Using experimental data from protein/DNA interaction arrays and gene expression microarrays we identified a list of TFs that are differentially regulated in HIV-1 transgenic mice, Tg26, as compared to their wild type (WT) littermates. We employed a computational biology and bioinformatics approaches to study signaling pathways status by taking into account protein-protein and protein-DNA interactions. Homeodomain interacting protein kinase 2 (HIPK2) was identified as a common regulator of signaling pathways activated in HIVAN. HIPK2 is known to mediate signaling through multiple pathways involved in tubular cell apoptosis, EMT, and tubulointerstitial fibrosis. The role of HIPK2 in HIVAN will be confirmed experimentally. (TFs: transcription factors; PPI: protein-protein interactions; KEA: kinase enrichment analysis; TGF: transforming growth factor; EMT: epithelial-mesenchymal transition.) that are activated by HIV in RTEC. Specifically, we will test whether HIPK2 engages in crosstalk with p53, TGF-β/Smad, Wnt/ β-catenin, and Notch pathways. Specific aim 2: Confirm the role of HIPK2 in vivo. 2A: Investigate whether and how HIPK2 knockout mice are protected from the development of tubulo- interstitial injury in the UUO model. 2B: Assess the efect of HIPK2 knockout on the development of tubulointerstitial injury and progression of kidney disease in Tg26. We believe that our proposed studies will have significant clinical relevance. HIPK2 could be a novel upstream signaling molecule activating multiple downstream pathways leading to tubulointerstitial injury, which is a final common pathway in the progression of chronic kidney disease. Our studies will also provide a novel approach to link upstream signaling pathways to data from gene expression microarrays. The iterative approach between experimental and computational/bioinformatics studies could help us to identify the key upstream kinases responsible for kidney injury in HIVAN and other kidney diseases.